Brain lymphatic activation for craniosynostosis and Alzheimer’s disease

PROJECT SUMMARY/ABSTRACT
The brain’s lymphatic system is composed of glia-lymphatic (glymphatic) and meningeal lymphatic branches.
The glymphatic branch, which is located in the brain parenchyma, transports cerebrospinal fluid (CSF) via
perivascular spaces (PVS) to clear neurotoxic molecules. It functionally connects with the brain’s surface-located
meningeal lymphatic vasculature for CSF drainage. While brain lymphatic impairment has recently been linked
with neurological disorders like Alzheimer’s disease (AD), traumatic brain injury (TBI), and craniosynostosis, the
regulatory mechanisms for brain lymphatic rejuvenation are largely unknown. The goal of this proposal is to
establish mechanisms rejuvenating brain lymphatics and exploit brain lymphatic activation as a new therapeutic
strategy for craniosynostosis and AD. The scientific premise is based on our recently published (Cell, 2021,
PMID: 33417861) and unpublished data (Cell Stem Cell 2023 in revision). Specifically, we established the first
animal model (Twist1+/-) of neurological defects in craniosynostosis and identified meningeal lymphatic vessel
(mLV) defect as a key driving factor for these cognitive defects. We also developed a mesenchymal stem cell
(MSC)-based suture regeneration approach. Using this approach, we successfully rescued neurological defects
by rejuvenating brain lymphatic functions in Twist1+/- mice, the well-established model for Saethre-Chotzen
syndrome with craniosynostosis. Our discovery of brain lymphatic rejuvenation in regeneration craniosynostosis
mice affords not only a new therapeutic strategy for treating craniosynostosis, it also provides a unique animal
model to investigate regulatory mechanisms underlying brain lymphatic rejuvenation. Preliminary data guide us
to hypothesize that MSC-LEC (lymphatic endothelial cell) crosstalk and the remodeling of AQP4 (glymphatic
system mediator) in regeneration craniosynostosis mice drive brain lymphatic rejuvenation, which can be
exploited to mitigate craniosynostosis and AD. Overall, building upon our published discoveries, the completion
of proposed studies will advance the field by developing stem cell-mediated treatments of craniosynostosis, filling
in missing mechanistic knowledge of meningeal lymphatic rejuvenation, and validating VEGF-C/AQP4 as
potential therapeutic targets for craniosynostosis and AD.

Public health relevance
PROJECT NARRATIVE The brain’s lymphatic system regulates fluid homeostasis and removes toxic macromolecules in brains. The goal of this project is to investigate how the brain lymphatic system can be rejuvenated to treat neurological disorders such as craniosynostosis and Alzheimer’s disease (AD). The outcome will help develop new therapeutic strategies against these devastating neurological diseases.